Determining the impact of cannabis use and severity on tobacco cessation outcomes: A prospective tobacco treatment trial

Project Summary/Abstract
This application is being submitted in response to the Notice of Special Interest (NOSI) identified as NOT-
CA-22-070: Administrative Supplements for Examining Patterns of Tobacco and Cannabis Use. This
supplement request will support additional data collection as part of the NCI-funded award (R37 CA237245, PI
McClure, 07/01/2019-06/30/2024) entitled, “Determining the impact of cannabis use and severity on tobacco
cessation outcomes: A prospective tobacco treatment trial.” The overall goal of the funded parent R37 MERIT
award is to conduct a prospective tobacco treatment study evaluating the impact of cannabis co-use on tobacco
cessation outcomes. The NOSI NOT-CA-22-070 supplement is an ideal fit for the funded parent award and will
allow for the addition of real-time, ecologically valid data collection via bursts of ecological momentary
assessment (EMA) on patterns of cannabis-tobacco co-use for participants enrolled in the parent trial. While the
parent study is collecting weekly data on patterns of cannabis and tobacco co-use, current measures may be
not be sensitive enough to categorize co-users into profiles of use patterns and determine relationships during
specific use events. The literature on cannabis-tobacco co-use suggests that a great deal remains unknown
regarding patterns of co-use, how patterns vary across those who co-use, and how co-use patterns may
adversely impact health and treatment outcomes. Real-time data collection on co-use patterns throughout the
parent tobacco treatment trial will provide more accurate and refined data on patterns of co-use to inform
treatment implications and future work in this area. For the 1-year supplement, we anticipate enrolling 48
cannabis-tobacco co-use participants to engage in additional EMA data collection. EMA data collection will be
conducted in four bursts across the trial to assess detailed patterns of cannabis-tobacco co-use among
participants, and how those patterns change during tobacco treatment. We will conduct 1-week bursts of EMA
data collection at 4 time points during the trial: 1) baseline/pre-medication, 2) Week 1 (starting at the target quit
date), 3) Week 11 (ending at the Week 12 end-of-treatment visit, and 4) Week 25 (ending at the Week 26 final
follow-up visit). By conducting multiple bursts of EMA data collection, we will be able to compare co-use patterns
within an individual across the pre-quit phase, treatment phase and at follow-up after medication has been
terminated. We will also be able to make comparisons in co-use patterns between participants to assess for
varying patterns of co-use. Together with the original aims of the R37 award, this supplement will allow for the
exploration of individual co-use patterns and changes in patterns during tobacco treatment among those who
co-use cannabis and tobacco. This additional data collection on patterns of tobacco-cannabis co-use will help to
inform the literature and provide preliminary data for follow-up studies focused on varying patterns of co-use and
their associated treatment implications among those who use tobacco and cannabis products.

Public health relevance
Project Narrative This application is being submitted in response to the Notice of Special Interest (NOSI) identified as NOT- CA-22-070: Administrative Supplements for Examining Patterns of Tobacco and Cannabis Use, as a supplement to the NCI-funded award (R37 CA237245, PI McClure, 07/01/2019-06/30/2024) entitled, “Determining the impact of cannabis use and severity on tobacco cessation outcomes: A prospective tobacco treatment trial.” The goal of this 1-year supplement is to integrate real-time, ecologically valid data collection via bursts of ecological momentary assessment (EMA) on patterns of cannabis-tobacco co-use for participants enrolled in the parent trial (N=48). A great deal remains unknown regarding patterns of cannabis-tobacco co-use, how patterns vary across those who co-use, and how co-use patterns may adversely impact health and treatment outcomes, which results of this study will help to inform.